Evaluating a Community-Led COVID-19 Testing Intervention to Address Mistrust

Project Summary
Our preliminary work with low-income Black residents in Southeastern and Central Virginia suggests that
preexisting mistrust in the public health establishment and other important government institutions has
worsened during the pandemic, affecting decision making about following public health guidance related to
COVID-19 testing and vaccination. In particular, participants in our current study report that a major barrier to
COVID-19 testing is the expectation that a positive result will be used against them. This suggests that trust-
building must be a cornerstone of any COVID-19 outreach efforts.
The goal of this proposal is to address these concerns through the development of a community-led
intervention co-developed with our partner Housing Collaborative Community Advisory Board (HC CAB). Our
HC CAB partners report that our relationships with them helped overcome mistrust common in their
communities. They described the way we interacted with them, rather than any specific content, led us to be
viewed as trustworthy. Engagement with a strong relationship building focus is thus likely an important
intervention in and of itself—in this study we will standardize a process of relationship and trust building to be
used as core components of a community-led intervention promoting rapid COVID-19 testing.
In Aim 1 we administer and evaluate a preliminary virtual Peer Mentor COVID-19 testing intervention
developed with our HC CAB partners. It uses a Peer Mentor model in which HC CAB members guide other
community members participating in the study through self-administering a rapid in-home test. The process will
be virtual, with HC CAB member Peer Mentors and participants using digital access capacity provided and
supported by the research team. In a second arm of the study participants will meet with research staff in
group sessions meant to approximate the experience of being a member of a community advisory board.
There will also be a control group which will only receive follow up assessment. In Aim 2 we use evaluation
data to develop an adapted COVID-19 testing intervention. In Aim 3 we administer the adapted intervention.

Public health relevance
Project Narrative The U.S. pandemic response has come at a significant cost in public trust in important institutions. Unfortunately, our past work suggests that this will likely continue to significantly undermine compliance with public health guidance moving forward, especially for people who are primed to be receptive to messaging that exploits existing mistrust. In this study we will implement, evaluate, and adapt a community-led COVID-19 testing intervention designed to promote rapid testing and increase trust.